A Randomized Trial to Minimize Non-Response to Aerobic Training in Operable Breast Cancer

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) is the primary cause of late mortality (death ≥5 yrs from diagnosis) in early breast
cancer (EBC). Effective treatment strategies that improve function across multiple systems are needed in order
to reduce CVD in EBC. Aerobic exercise therapy (AT) is a multisystem intervention demonstrated to improve
cardiorespiratory fitness (CRF), a strong, independent predictor of CVD and all-cause mortality in breast and
other malignancies. However, in our prior AT trial in EBC, our group found that despite high AT adherence, CRF
change ranged from -10% to +24%, and ~60% of participants were classified as CRF non-responders. These
findings indicate that AT following the conventional volume (~150 min/wk) and / or length (~16 wks) is insufficient
for improving CRF in a substantial proportion of EBC survivors. The objective of the parent trial is therefore to
evaluate the effects of increasing AT program length and volume on CRF response rate and other pertinent
outcomes in EBC. We hypothesize that results from the parent trial will show that higher volume and length of
AT will improve CRF response rate compared to standard dosing. However, we expect critical knowledge gaps
will remain. The proposed R37 extension will allow us to address these gaps by further investigating CRF
response to AT, the long-term effects of AT, and explore facilitators and barriers to AT. For the proposed
extension, we will build on the funded parent trial by extending the follow-up of participants to 1-year post-
intervention, providing a long-term assessment of CRF in the post-treatment survivorship period. We will address
3 specific aims: AIM 1: Examine baseline factors associated with CRF response. AIM 2: Evaluate the long-term
effects of AT dosing on CRF and patient reported outcomes. AIM 3: Explore AT implementation outcomes.
IMPACT: A history of cancer treatment is not a qualifying condition for structured AT and, as such, AT is not
currently considered a standard aspect of cancer management. The proposed study will fill significant exercise-
oncology knowledge gaps and will support AT implementation in clinical cancer care.

Public health relevance
PROJECT NARRATIVE Chemotherapy for early-stage breast cancer causes significant declines in cardiorespiratory fitness (CRF) predisposing patients to increased symptom burden and increased risk of morbidity and mortality. We propose to evaluate characteristics associated with CRF response to aerobic training, examine the long-term effects of aerobic training, and explore implementation of aerobic training. Results from this investigation will provide essential evidence supporting integration of aerobic training into clinical cancer care.